Mechanisms of Transient Transcription in Yeast

DESCRIPTION (provided by applicant): The spatial and temporal expression of specific gene sets is critical for the execution of complex differentiation programs. The long-term goal of this study is to mechanistically define transient transcription in the context of the budding yeast meiotic differentiation program. Many genes required for the meiotic landmark events are repressed during mitotic cell division but then transiently induced during development in temporal waves termed early, middle and late. Ume6p binds early meiotic gene promoters and mediates their vegetative repression by recruiting both histone deacetylase (HDAC) and chromatin remodeling complexes. We have recently discovered that early meiotic gene induction requires Ume6p destruction by the Cdc20p- directed anaphase promoting complex/cyclosome (APC/C) ubiquitin ligase. Although well known for its role in controlling the G2 -> M transition in mitotic cells, this is the first report that APC/CCdc20 targets a transcription factor for destruction. In addition, Ume6p destruction is restricted to cells entering meiosis, even though APC/CCdc20 is active (and Ume6p is present) during mitotic cell division. The meiotic inducer Ime1p provides a trigger to promote Ume6p destruction thus suggesting a new mechanism by which APC/C substrate selection is redirected within the context of a differentiation program. While searching for potential meiosis-specific destruction signals, we discovered that Ume6p is a substrate of the Gcn5p histone acetyltransferase (HAT) complex called SAGA. The well-studied acetylation and deacetylation of nucleosomes maintains chromatin in open and closed configurations, respectively. However, the acetylation of transcription factors has not been demonstrated previously in yeast and has only been described for a few transactivators in mammalian systems. To our knowledge, Ume6p is the first transcriptional repressor found to be acetylated. Interestingly, preliminary results point to a role for acetylation in both preventing Ume6p DNA binding ability and enhancing its degradation. These findings suggest a new model for Gcn5p-dependent transcriptional activation through direct inhibition of Ume6p repressor function. Following induction, meiotic gene expression and the execution of landmark events are coupled by a series of checkpoint systems. Preliminary results indicate that Ume6p destruction is prevented upon activation of the DNA damage checkpoint. The mechanism by which Ume6p is protected from destruction following checkpoint activation, or the role of additional checkpoint pathways, is unknown. To understand the molecular mechanisms by which Ume6p-dependent repression is relieved upon meiotic induction, and how repression is reestablished in response to checkpoint pathways, the following aims are proposed: Aim1. Dissect the molecular mechanisms directing developmental re-tasking of the APC/C. Aim2. Determine the role that acetylation plays in Ume6p activity and regulation. Aim3. Identify and characterize the meiotic pathways that mediate Ume6p destruction.

Public health relevance
PUBLIC HEALTH RELEVANCE: During normal development, gene expression is precisely controlled to provide the correct gene product at the correct time. Failure to execute the proper gene expression program can lead to developmental defects or embryonic lethality. This proposal describes experiments to understand how these transcription programs are regulated when cells undergo development. During normal development, gene expression is precisely controlled to provide the correct gene product at the correct time. Failure to execute the proper gene expression program can lead to developmental defects or embryonic lethality. This proposal describes experiments to understand how these transcription programs are regulated when cells undergo development. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS. The spatial and temporal expression of specific gene sets is critical for the execution of complex differentiation programs. The long-term goal of this study is to mechanistically define transient transcription in the context of the budding yeast meiotic differentiation program. Many genes required for the meiotic landmark events are repressed during mitotic cell division but then transiently induced during development in temporal waves termed "early", "middle" and "late". Ume6p binds "early" meiotic gene promoters and mediates their vegetative repression by recruiting both histone deacetylase (HDAC) and chromatin remodeling complexes. We have recently discovered that early meiotic gene induction requires Ume6p destruction by the Cdc20p- directed anaphase promoting complex/cyclosome (APC/C) ubiquitin ligase. Although well known for its role in controlling the G2 -> M transition in mitotic cells, this is the first report that APC/CCdc20 targets a transcription factor for destruction. In addition, Ume6p destruction is restricted to cells entering meiosis, even though APC/CCdc20 is active (and Ume6p is present) during mitotic cell division. The meiotic inducer Ime1p provides a trigger to promote Ume6p destruction thus suggesting a new mechanism by which APC/C substrate selection is redirected within the context of a differentiation program. However, the presence of Ime1p alone is insufficient to induce Ume6p destruction indicating the presence of additional destruction signals. While searching for potential meiosis-specific destruction signals, we discovered that Ume6p is a substrate of the Gcn5p histone acetyltransferase (HAT) complex called SAGA. The well-studied acetylation and deacetylation of nucleosomes maintains chromatin in "open" and "closed" configurations, respectively. However, the acetylation of transcription factors has not been demonstrated previously in yeast and has only been described for a few transactivators in mammalian systems. To our knowledge, Ume6p is the first transcriptional repressor reported to be acetylated. Interestingly, preliminary results point to two separate regions of Ume6p that are acetylated. Mutational analysis suggests acetylation of one region induces Ume6p destruction while modification of the other interferes with DNA binding. These findings suggest a new model for Gcn5p-dependent transcriptional activation through direct inhibition of Ume6p repressor function. Following induction, meiotic gene expression and the execution of landmark events are coupled by a series of checkpoint systems. Preliminary results indicate that Ume6p destruction is prevented upon activation of the DNA damage checkpoint. The mechanisms by which Ume6p is protected from destruction following checkpoint activation, or the role of additional checkpoint pathways, is unknown. To understand the molecular mechanisms by which Ume6p-dependent repression is relieved upon meiotic induction, and how repression is reestablished in response to checkpoint pathways, the following aims are proposed: Aim1. Dissect the molecular mechanisms directing developmental re-tasking of APC/CCdc20. Many steps exist in the acquisition of a substrate by the APC/C including activator binding and association to the ligase itself. Using a combination of in vitro binding assays and in vivo activity studies, the role of Ime1p in mediating Ume6p destruction will be ascertained. In addition, the regulatory cascade governing Ume6p-Ime1p interaction will be elucidated. Aim2. Determine the role that acetylation plays in Ume6p activity and regulation. A combination of biochemical and genetic studies will be utilized to determine the role of acetylation on Ume6p DNA binding and stability. Next, we will test a model that the opposing activities of the HAT and HDAC complexes that regulate EMG transcription control Ume6p acetylation DNA binding and stability. Aim 3. Identify and characterize the meiotic checkpoint pathways mediating Ume6p destruction. First, the checkpoint pathway governing Ume6p stabilization following DNA damage will be identified and the mechanism inactivating APC/CCdc20 will be elucidated. Next, we will determine whether Ume6p stability is controlled by checkpoint pathways that monitor meiotic recombination and chromosome segregation.